Leveraging invasive recordings and immersive virtual reality to characterize freezing of gait mechanisms in Parkinson disease

PROJECT SUMMARY/ABSTRACT
Freezing of gait (FOG) is a disabling symptom in advanced Parkinson’s disease (PD) with inadequate
treatment options. The pathophysiology of FOG is poorly understood, likely contributing to disappointing results
of novel neuromodulation strategies. The goal of this proposal is to identify electrophysiological mechanisms of
FOG that can serve as biomarkers for novel neuromodulation strategies. Activity in the globus pallidus internus
(GPi), the major output nucleus of the basal ganglia, is central to understanding basal ganglia contributions to
gait impairment, as it provides insights into activity that downstream locomotor circuits read out from the basal
ganglia. The project leverages a state-of-the-art multimodal brain/behavior recording platform and recent
advances in sensing deep brain stimulation devices to record neural activity from the human GPi
simultaneously with electroencephalography (EEG), motion capture and eye gaze during over-ground walking
and FOG episodes in PD patients with and without FOG. To reliably elicit FOG episodes and improve external
validity, we implement a novel immersive virtual reality environment to recapitulate real-world scenarios that
commonly trigger FOG. With these tools, the proposed studies will determine how gait-related neural
oscillations in the beta (12-30 Hz) and theta/alpha (4-12 Hz) bands in the GPi and cortex relates to abnormal
gait during continuous walking (Aim 1); the onset and recovery from FOG episodes (Aim 2); and the
therapeutic benefits from external cues (Aim 3). This paves the way for multiple innovative neuromodulation
strategies that (1) prevent FOG episodes by promoting normal or compensatory gait control during continuous
walking and (2) ameliorate severity of FOG episodes by targeting signals associated with FOG onset and
recovery. Additionally, it establishes a novel VR paradigm for future precision-medicine approaches to FOG
therapeutic development.

Public health relevance
PROJECT NARRATIVE Freezing of gait – the inability to start or continue walking – is a particularly disabling problem in Parkinson’s disease that has few treatment options. This project records human brain activity during walking and freezing of gait episodes to understand the pathophysiology of freezing of gait. Findings will lay the foundation for the development of new treatment strategies that address this disabling symptom.